Administrative Core

CORE SUMMARY / ABSTRACT
The Administrative Core will manage the budgetary, administrative, and communication aspects of this Program.
The Core will be responsible for coordinating meetings and interactions among investigators, transmitting data,
communicating with NIH program personnel, preparing publications and maintaining a bibliography describing
work performed, and all relative financial matters. The Program Manager will act as liaison with the hospital's
financial office, office of research affairs, and materials management. The Administrative Core also includes a
program statistician, who is available for consultation on study design, calculation of sample size, and for analysis
of data from the animal studies.